In Vivo Efficacy of Novel Uncharged Bis-Oximes in OP Poisoning Treatment

In vivo efficacy of novel uncharged bis-oximes in OP poisoning treatment.
Project Summary. Nucleophilic oxime reactivators of organophosphate (OP) inhibited
acetylcholinesterase (AChE) are the only true antidotes against OP intoxication in nerve agent or
OP pesticide exposure.
One significant way of improving current antidotal treatment of OP intoxication is by creation
of reactivating antidotes that will reach inhibited AChE in peripheral tissue but also in the CNS,
where currently approved antidotes cannot enter. Using X-ray structural analysis of RS194B
uncharged acetamido aldoxime that has been shown to reactivate inhibited AChE in vivo, both
centrally and in periphery, albeit at high dose, we have designed and characterized in vitro
(Gorecki et al.,2020) seven improved uncharged LG bis-oxime antidotes with better reactivation
of sarin, cyclosarin, VX and paraoxon inhibited hAChE than RS194B.
Preliminary toxicity and pharmacokinetic studies in mice for the three most promising LG-
oximes by the CPDF of the CounterAct program are ongoing (SRI Project P24997) indicating no
toxicity up to 160 mg/kg i.m. which is better than 2PAM, and is approaching low toxicity of
RS194B. Initial in vivo therapy of LG-703 done at IMROH, tested in mice superior to RS194B.
We propose for this study to evaluate in vivo in mice, therapeutic efficacy of three best LG-
oximes upon animal exposure to representative nerve agent OPs and to selected OP pesticides
and evaluate pharmacokinetic profile and neuroprotection for the most efficacious LG bis-oxime.
Promising outcomes, of the ongoing preliminary in vivo experiments in mice and of completed
in vitro characterizations, provide substantial hope for good antidotal potential of this novel class
of centrally active, uncharged bis-oximes, and good prospects for their future therapeutic use.

Public health relevance
In vivo efficacy of novel uncharged bis-oximes in OP poisoning treatment. Project Narrative. This project is directed to in vivo testing of novel directed library of uncharged bis-oxime antidotes in mice exposed to nerve agent and pesticide organophosphates, and evaluation of their PK profiles and neuroprotection potential in mice.